Development and validation of diffusion-model enabled computational observers for clinical diagnostic task performance evaluation of deep learning CT algorithms

Objective assessment of image quality (IQ) using task-based performance metrics is important for developing
deep-learning image reconstruction and post processing algorithms, and for translating the champion
algorithms to the clinics. Ideally, task performance evaluation should use human observers. But human
observer studies are time consuming and expensive, therefore cannot be realistically applied to evaluating and
optimizing algorithms during early-stage development. Computer-based human-performance mimicking model
observers (MO) can substitute for human observers and hold great potential as a tool for IQ evaluation.
However, MO studies are not often used for DL algorithm evaluation. One possible reason could be due to
the weaknesses of MOs for task performance evaluation. Diagnostic tasks are complicated due to imperfect
data acquisition, e.g., quantum noise, and the large patient anatomical variation. Historically, the patient
anatomical variation is quantitatively intractable, while the quantum noise can be handled well by the known
data acquisition model. In this context, the current paradigm of MOs circumvents our inability to quantify patient
anatomical variation, but relies on multiple realizations of quantum noise to define a patient population. This
approach leads to the intertwined weaknesses of (1) simplified task definitions and (2) burdensome data
requirement, which may attribute to the absence of MOs in DL algorithm evaluation.
The challenge of characterizing patient anatomical variation can now be overcome, thanks to the advent of
score-based probabilistic diffusion models (DMs). Score-based DMs, in addition to generating image samples
as in all generative models, have the unique capability of calculating the exact log-density (or log-likelihood) of
image samples. This capability can be exploited to calculate (log-)likelihood ratio type test statistics and allows
us to define a new paradigm of MOs for realistic clinical tasks with free-form, essentially unlimited signal and
background variability, here “unlimited” means “to the extent of variation that the DM training data are curated
for.” At the same time, relying on anatomical variation reduces the burdensome, multiple noise, data
requirement, so that our new MOs are also data-efficient and applicable to patient data that do not come with
multiple noise realizations.
Our specific aims focus on (1) developing the computational framework of such diffusion-model enabled
MOs, (2) validating MO performance using clinical detection and localization tasks. Our MOs break free from
the historical confines that have hindered their adoption for routine task-performance evaluation of diagnostic
image quality. They hold great potential for identifying promising early-stage algorithms, for offering a
performance predictor that correlates well with diagnostic task performance, and for eventually translating the
champion algorithms to clinical deployment for improved patient care.

Public health relevance
Deep learning (DL) CT image reconstruction or post-processing are advanced computer algorithms that can potentially improve disease detection and help doctors make more confident decisions. Currently, these DL algorithms cannot be evaluated effectively and efficiently on complex clinical tasks with heterogeneous patient population and varying disease status. We aim to develop a tool to perform such evaluation so as to identify promising DL algorithms with predictable high performance in a clinical setting.